Biological Systems Core

ABSTRACT
Adverse childhood experiences (ACEs) result in enduring changes to the body’s endocrine, metabolic,
immune, and nervous systems that contribute to dysregulated stress responses and health-harming coping
behaviors (smoking, alcohol, and illicit substance abuse, overeating and obesity), ultimately leading to the
mental and physical illnesses observed in large-scale epidemiological studies of ACEs (e.g., cardiovascular
disease, autoimmune diseases, depression, and suicide). As a result, achieving CIRCA’s Phase 2 aims will
require building a robust physical infrastructure and intellectual support for the collection, storage, analysis,
and interpretation of data from across diverse biological systems. The mission of the CIRCA Biological
Systems Core is thus to support phase 2 CIRCA investigators as they incorporate into their projects a broad
range of biological research methods, including genetics and gene expression (e.g., sequencing and RT-PCR),
epigenetics (e.g., pyrosequencing), protein measurements (e.g., MSD and ELISAs), immunophenotyping (e.g.,
flow cytometry and ELISPOT), brain structural and functional imaging (e.g., MRI, fMRI, and functional near-
infrared spectroscopy), and psychophysiology (e.g., electromyography, heart rate variability, etc.), as well as
remote biosensors and sample collection technologies (e.g., Oura rings, Cyto-Chex cell stabilization tubes,
etc.). The first Aim of the phase 2 CIRCA Biological Systems Core will be to provide Research Project Leaders
(RPLs) with access to the laboratory space to collect the biosamples and biological data required to complete
their project goals, the equipment to store and analyze those samples and data, and the domain expertise and
training necessary for valid interpretation and scientific inference from the analytical results. The second Aim
of the Biological Systems Core will be to provide phase 2 CIRCA RPLs and pilot project scientists with
common biological data elements, a biosample repository, and clinical registry that will provide training
opportunities and pilot data for papers and grant proposals by faculty across the OSU system focused on
advancing adversity and resilience science. The Biological Systems Core will standardize across all
participants in phase 2 CIRCA projects the collection, storage, and analysis of common biological data
elements related to the endocrine, metabolic, immune, and neural consequences of ACEs. The resulting
databank of ACEs-related biological data in a large number of participants will be an invaluable resource to all
current and future phase 2 CIRCA scientists. In addition to common biological data elements, the Core will
create a long-term repository of biological samples that will be available to future CIRCA pilot-project scientists
with novel hypotheses about the biological consequences of ACEs. The Core will also contribute to the
creation of a clinical registry that will marry clinical and biosample data with assessments of ACEs and
protective factors in OSU Medicine patients, supporting future studies of the clinical consequences of ACEs.

Public health relevance
NARRATIVE Achieving the Phase 2 aims of the Center for Integrative Research on Childhood Adversity (CIRCA) will require building a robust physical infrastructure and intellectual support for the collection, storage, analysis, and interpretation of data from across diverse biological systems. The CIRCA Biological Systems Core will thus support phase 2 CIRCA investigators as they incorporate into their research a broad range of biological measurements, and provide common biological data elements across projects, a clinical registry, and a biosample repository that will collectively offer training opportunities and pilot data for papers and grant proposals from scientists focusing on advancing adversity and resilience science.